Breaking up Prolonged Sedentary Behavior to Improve Cardiometabolic Health: An Adaptive Dose-Finding Study

Excessive sedentary behavior is highly prevalent in developed nations and is a risk factor for cardiovascular
disease (CVD) morbidity and mortality. Evidence suggests sedentary behavior is not simply a form of inactivity
that elicits positive energy balance. Instead sedentary behavior itself may be harmful. As such, health agencies
have provided general recommendations to “sit less, move more” by interspersing brief periods of activity.
However, a lack of empirical evidence describing how often (e.g. every 30 min, every 60 min) and for how long
(e.g. 1 min activity bouts, 5 min activity bouts) sedentary time should be interrupted (a “sedentary break”) to
yield health benefit has precluded more quantitative, actionable guidelines. To date, rigorous and methodical
dose escalation experiments have not been conducted to elucidate efficacious and tolerated sedentary break
doses. Without specific targets to provide to the public; public health initiatives targeting sedentary behavior will
likely have minimal effectiveness. Critically, without rigorously tested dosing information; randomized controlled
trials targeting sedentary behavior may be fruitless; bearing risk of inefficacious or intolerable doses. The
objective of the proposed study is to determine the minimally effective dose (e.g. the smallest dose) for two
elements of a sedentary break, frequency and duration, that yields improvements in established CVD risk
factors. We will also determine the maximally tolerated dose (e.g. the highest dose that does not cause undue
physical/psychological distress) for both frequency and duration of sedentary breaks. To address our aims, we
will conduct a state-of-the-art dose finding study under well controlled laboratory conditions using an innovative
Bayesian adaptive randomization method for dose determination never before applied to behavioral trials. This
method will enable us to efficiently test 25 possible frequency/duration combinations in just a single study. We
will recruit 324 adults to complete a total of 2 trial conditions in the laboratory (8 hours each), namely a
sedentary break (active) condition and an uninterrupted sitting (control) condition, in a randomized order. The
sedentary break condition will consist of 1 of 25 possible frequency/duration combinations (e.g. every 30 min
for 10 min), selected according to the adaptive randomization protocol. Established CVD risk factors, including
blood pressure and glucose, as well as measures of dose tolerability (physical exhaustion/fatigue, affect) and
work engagement and performance will be serially assessed during each trial. We view this project as a
groundbreaking step towards developing evidence-based guidelines for sedentary behavior that will establish a
foundation upon which a successful sedentary behavior intervention development process can be rooted. By
identifying the minimally effective and maximally tolerated dose combinations for the frequency and duration of
a sedentary break; this study will provide key foundational evidence critical to the success of future Phase III
and Phase IV randomized trials and ultimately public health guidelines.

Public health relevance
Adults in developed nations are sedentary for nearly two-thirds of the day- often for hours at a time- which greatly increases risk for cardiovascular disease and mortality. The Physical Activity Guidelines for Americans have recently expanded beyond promoting moderate-vigorous intensity physical activity and now also advocate for reductions in sedentary time; however due to a paucity of evidence only general recommendations (“sit less, move more”) have been provided without any specific, quantitative, actionable targets. This adaptive dose finding study will determine how often and for how long people should break up periods of prolonged sedentary time to transiently improve established cardiovascular risk factors; key foundational information critical to the success of future long-term trials and ultimately public health guidelines.